Core B: Morphology-Meyerholz

CORE B – MORPHOLOGY
SUMMARY/ABSTRACT
The purpose of the Morphology Core is to provide professional services and expertise to all
Investigators of the Cystic Fibrosis Program Project. The Morphology Core will provide: 1)
technical assistance for labor intensive histotechnology techniques from tissue processing to
specialized staining, 2) professional veterinary pathology support for gross and microscopic
evaluation of tissues for CF pig studies, 3) consultation and instruction in specialized
morphologic techniques and image analysis and 4) economic benefits through centralization of
equipment, experienced professional staff and availability of specialized reagents. Program
Investigators will have full access to the Morphology Core's expertise and resources, and Core
personnel will provide services to Program Investigators in a timely and efficient manner.

Public health relevance
CORE B – MORPHOLOGY PROJECT NARRATIVE The Morphology Core will provide histotechnology and pathology services to Investigators of the Program Project Grant (PPG). This will enhance the quality and reproducibility of studies to better understand CF pathogenesis and facilitate more effective lung disease therapies.